Chemical Biology Interface Training Grant

Start with Principal Investigator. List Name Kiessling, Laura L. Thorson, Jon Belshaw, Peter Burstyn, Judith Burke, Steve McEIroy, Erin Raines, Ronald Ruoho, Arnold Shen, Ben Use continuation pages as needed to provide the required information all other key personnel in alphabetical order, last name first. Organization UW-Madison UW-Madison UW-Madison UW-Madison UW-Madison UW-Madison UW-Madison UW-Madison UW-Madison [unreadable] . o . . . PHS 398 (Rev. 05/01) Page 2 in the format shown below. Role on